Completing a second Risk Factor Study and Standard 2 curriculum courses for all Regulatory Food Inspection Staff in Rockingham County North Carolina

Project Summary/Abstract Rockingham County Environmental Health (RCEH) enrolled in the U.S. Food and Drug Administration (FDA) Voluntary National Retail Food Regulatory Program Standards (VNRFRPS) on September 29, 2014. The initial self-assessment was completed on August 27, 2015 and a baseline risk factor study was completed in 2016. Currently, VNRFRPS 1, 3, 4, and 9 have been met and the second self-assessment will be completed by August 2020. The funding from this grant (FOA # RFA-FD-20-012) will be used to purchase new inspection software and laptop computers for the Food Safety Inspection Officers (FSIO), employee salaries for time spent working on the VNRFRPS, and to purchase educational materials that will be used in conjunction with RCEH’s intervention strategies and manager/person in charge (PIC) training. The technology purchased will allow FSIOs to be more efficient and productive in the field and will track risk factor and public health intervention violations more accurately to improve compliance and enforcement. Furthermore, the software will more thoroughly document observations noted during inspections, improve reporting capabilities, and enhance the public interface with easy access to online retail food inspection reports. The second risk factor study, which will be completed by the end of June 2021, will allow FSIOs to determine if the intervention strategies implemented at the conclusion of the baseline risk factor study were effective at reducing the highest out of compliance risk factors. The methodology developed by the FDA will be utilized for conducting the second data collection including training data collectors; selecting facility types; and collecting, analyzing and interpreting data. RCEH will use the FoodSHIELD portal to analyze data and to develop an updated targeted intervention strategy. This data will eventually be used to complete a trend analysis to determine if there has been an overall reduction of foodborne illness risk factors. Additional educational materials will be purchased to address out-of-control risk factors as part of the updated intervention strategies. In addition, RCEH would like to develop a targeted manager/PIC training and remedial training for employees at establishments with out-of-control risk factor violations, purchase certified food protection manager courses to be offered free of charge and have educational materials translated into multiple languages. This funding is imperative because without it RCEH will not receive the financial means and support that is necessary from the County Manager, Board of County Commissioners or the Board of Health and Human Services to continue its advancement in the VNRFRPS.

Public health relevance
Project Narrative This grant (FOA # RFA-FD-20-012) will be used to purchase new inspection software and laptop computers for the Food Safety Inspection Officers (FSIO), reimburse the county for employee salaries for time spent working on the Voluntary National Retail Food Regulatory Program Standards (VNRFRPS) and to purchase educational materials for food service employee training. This funding is important because it will provide Rockingham County Environmental Health (RCEH) the ability to purchase tools which will allow FSIOs to become more efficient in the field when writing reports, improve compliance and enforcement as a program, conduct a second risk factor study, reassess existing intervention strategies and develop new training programs for food service employees. By continuing to meet and maintain VNRFRPS, RCEH will reduce or eliminate the occurrence of foodborne illnesses and will provide a solid foundation for improving the retail food inspections program.